TRACE METAL ALTERATION OF RENAL PORPHYRIN METABOLISM

The kidney is a principal target organ for numerous toxic trace metals. Current evidence suggests that porphyrinuria, an early pre-toxic manifestation of prolonged metal exposure, is predominantly of renal origin, and may, therefore, serve as a diagnostic indicator of ensuing metal toxicity in the kidney. In studies on the mechanisms by which methyl mercury (MMH) elicits renal porphyrinuria, 3 principal biochemical events which appear to underlie this process have been identified. These are: (1) metal-induced depletion of renal reduced glutathione (GSH) content, (2) consequent impairment of renal uroporphyrinogen decarboxylase (UD), and (3) a delayed increase in renal ALA synthetase activity. It is hypothesized that metal-induced depletion of renal GSH leads to deactivation and/or inhibition of UD, causing a primary block in renal porphyrin metabolism. GSH depletion also enhances heme catabolism, leading to a secondary induction of ALA synthetase with subsequent porphyrin overproduction. These changes are manifested as porphyrinuria. Studies are proposed to delineate the precise mechanisms by which each of these changes is elicited using MMH-induced porphyrinuria in rat kidney cortex as the experimental model. A highly sensitive HPLC-spectrofluorimetric assay developed in these laboratories will be used to quantitate porphyrins in tissue and assay media and to study the mechanisms of metal and GSH effects on renal porphyrin metabolism. Specific GSH depeting and repleting agents will be used to assess the interaction of GSH with renal heme and porphyrin regulation during prolonged metal exposure. The relationship of these events to lipid peroxidation and formaldehyde formation, as potential toxic sequellae of metal-induced GSH depletion in kidney cells, will also be investigated. The proposed studies will add substantially to the current understanding of the regulation of heme and porphyrin metabolism in the kidney and the role of GSH in this process. In demonstrating the mechanisms by which metals impair GSH and heme regulation during prolonged, low-level exposure, and the relationship of these events to known causes of tissue damage, these studies will provide a biochemical basis for understanding how metal toxicity is initiated in renal cells. Evidence that porphyrinuria is a magnifestation of pre-toxic biochemical events associated with trace metal exposure will lend diagnostic significance to porphyrinuria in the detection and prevention of chronic metal toxicity.